Sustained Delivery of RhoA activator for Treatment of Intervertebral Disc Degeneration

This application is for a diversity supplement for a post-baccalaureate student who will be doing
a year-long mentored research experience in the lab of the PI, Dr. Nadeen Chahine’s on a
research project related to this NIH parent award. The candidate’s career goals are to become a
physician scientist, specializing in orthopedics and musculoskeletal medicine. The candidate is
an engineer (U.S. citizen) from an underrepresented race/ethnic group in STEM, as defined by
the guidelines provided by NSF and NIH on workforce diversity. The candidate’s research training
in orthopedic research at Columbia University enhances the diversity of the biomedical research
workforce. The diversity supplement project will examine the effects of aging and degeneration
on RhoA signaling and actomyosin contractility of IVD. The diversity supplement project is a direct
extension of the scope of the parent R21 project on sustained delivery of RhoA activator for
treatment of intervertebral disc (IVD) degeneration. This project is expected to advance
therapeutic treatment of disc degeneration and back pain.

Public health relevance
Discogenic back pain, is a leading cause of disability, and involves degenerative changes of the intervertebral disc. Only a small subset of patients responds favorably to existing treatments, and there is a need for alternative options, including regenerative therapies. We are developing a new medication that can be applied locally to the disc in the spine to revitalize the disc cells and reverse the painful degeneration, in hope that it improves outcomes for patients with back pain.